Targeting chitin in fibrotic lung disease

ABSTRACT
Healthy lung function is maintained by epithelial cells that comprise the barrier between environmental
constituents and host tissues. These cells become dysregulated in chronic inflammatory and fibrotic lung
disease, reflecting both genetic and environmental contributions. We have identified a novel association
between an abundant environmental polysaccharide and the progression of lung fibrosis. This polysaccharide,
chitin, accumulates abnormally in the airways of humans with idiopathic pulmonary fibrosis (IPF), an
irreversible, fatal interstitial lung disease that is not completely understood. IPF has been linked to alveolar
epithelial cell dysfunction and unknown environmental factors. Chitin is normally degraded by acidic
mammalian chitinase (AMCase), a chitinolytic enzyme conserved in mice and humans that is secreted by lung
epithelial cells to mediate chitin clearance from the airways. Our results indicate that AMCase is produced by
epithelial cells that may be directly involved in the pathogenesis of lung fibrosis. Environmentally-derived chitin
spontaneously accumulates in the airways of mice lacking AMCase or bearing IPF-associated genetic
mutations, coincident with the development of age-related lung fibrosis in both strains. Additionally, whereas
wild-type mice resolve fibrosis after acute epithelial injury, AMCase-deficient mice progress to severe interstitial
lung fibrosis associated with increased mortality, resembling key aspects of human fibrotic lung disease that
have been difficult to recapitulate in animal models. Together, these data suggest that the routine process of
degrading insoluble chitin particles in the airways is dysregulated in lung fibrosis and may be a relevant
environmental driver of disease. We have generated several genetic knockout, transgenic, and reporter mice
that enable the tracking and functional assessment of relevant lung epithelial cell populations. These different
mouse strains will be used to dissect the contributions of the mammalian chitinolytic system and associated
epithelial cells to the development of lung fibrosis. We will characterize the molecular mechanisms of chitin
degradation using novel assays incorporating common human and mouse enzyme variants on complex
substrates. These assays are coupled with in vivo approaches that will allow for rapid testing of therapeutic
candidates that can target natural substrates in a lung fibrosis setting. Thus, in this project, we propose
coupling therapeutic chitinase development with the study of how chitin drives fibrotic lung disease in three
aims: 1. To determine the contribution of environmental chitin to lung fibrosis. 2. To define the cellular and
molecular basis for chitinase activity in fibrotic disease. 3. To characterize the mechanisms of chitin
degradation mediated by human chitinases and test novel therapeutic approaches in vivo. Understanding
ways to efficiently target and degrade chitin in the context of fibrotic lung disease may advance new therapies
for a group of related diseases that currently lacks effective treatments.

Public health relevance
PROJECT NARRATIVE This project will study how the accumulation of chitin, a widespread environmental polysaccharide, influences lung fibrosis, which spontaneously develops when epithelial function or chitinase activity is impaired. Since chitinase activity is normally present in the airways of mice and humans, we will characterize the chitinase- producing epithelial cells and test whether defective chitin degradation can be targeted by approaches designed to improve enzyme activity and restore epithelial cell function. Understanding the mechanisms by which chitin degradation preserves lung function may provide new therapeutic options in human fibrotic lung diseases.